Neurovascular Adhesion Receptors and Barrier Integrity

DESCRIPTION (provided by applicant): Ischemic stroke produces rapid profound loss of microvascular integrity. Early following focal ischemia detectable disruption in the permeability barrier of cerebral microvessels occurs, with rapid loss of the endothelial cell β1 integrin-matrix receptors. In amyloid angiopathy, microvessel alterations increase the risk of microhemorrhages. The hypotheses to be tested by this competing renewal Proposal state that i) the interaction of matrix receptors on microvessel endothelial cells (and astrocytes) with matri components of the basal lamina are a major determinant of the blood-brain barrier phenotype, ii) focal cerebral ischemia disrupts receptor-matrix interactions, and iii) interruptions of receptor-matrix interactions result in loss of the blood brain barrier phenotype. We have shown that adhesion of endothelial cells to the intact basal lamina matrix is central to the integrity of the barrier. The barrier phenotype (e.g. tight junctions (TJs)) and vascular matrix are generated by endothelial cells and astrocytes in concert, and are maintained by both cell compartments. The expression of β1 integrins on endothelial cells and αβ-dystroglycan on astrocytes in vivo, and their responses to focal ischemia, are mimicked by primary endothelial cells and astrocytes of murine origin in culture. These responses are matrix-dependent. Based upon successful completed work and preliminary data, we propose that β1 integrins can determine TJ protein expression, and constitute the vertical component of the blood- brain and matrix barriers. The goal of this Project is to demonstrate that the actions of specific β1 integrin family members are required for the integrity of the microvessel barrier, and those specific integrin inhibitors, geneic constructs and knockdowns, focal ischemia, and Aβ1 peptides disrupt the receptor-matrix interactions, producing barrier failure. The Specific Aims are to demonstrate that: 1) the interactions of β1 integrins on confluent endothelium with matrix proteins determine inter-endothelial cell cohesion by the TJ proteins, and these are modulated by astrocytes, 2) mechanisms of β1 integrin signaling within endothelial cells mediate the matrix adhesion receptor-mediated changes in TJ expression (without or with astrocytes), 3) experimental ischemia significantly alters endothelial cell TJ expression by altering the endothelial cell β1 integrin-matrix interactions, and 4) the exposure of endothelial cells (without or with astrocytes) to Aβ-peptides modulates TJ expression and the microvessel permeability barrier phenotype via β1 integrin-dependent mechanisms. These novel studies provide a plausible explanation for the disruption of microvessel integrity immediately following focal ischemia and by amyloid angiopathy. The vertical component mediated by endothelial β1 integrin-matrix adhesion suggests the premise that its disruption is responsible for loss of the blood-brain barrier. Understanding the mechanisms of the β1 integrin-matrix adhesion is likely to lead to new testable approaches to preserve or selectively alter microvessel barrier function in other neurovascular disorders.

Public health relevance
Ischemic stroke is a devastating disorder that disrupts important bonds between the cells lining the small blood vessels of the brain (microvessel endothelial cells), that are thought to prevent leakage of fluid from inside the vessels, causing blood leakage and brain swelling. We have recently found that molecules (�1 integrins) that bind the endothelial cells to the scaffolding they sit on (matrix) within each microvessel are essential for maintaining the normal barrier to leakage, and that ischemic stroke quickly disrupts �1 integrins, thereby causing leakage to occur. This continuing research work will define the exact mechanisms by which endothelial cell �1 integrin-matrix binding maintains the barrier, and how its loss contributes to brain injury during ischemic stroke and other brain vascular disorders: fundamental studies needed for the development of new treatment strategies for stroke.